Mechanisms of motor superperformance

MECHANISMS OF MOTOR SUPERPERFORMANCE: ABSTRACT
Clinical experience and world population-level data indicate that most neurological disability stems from motor
dysfunction. Yet, spontaneous superperformer mutations occur in a variety of species including man,
illustrating that the intrinsic motor capacity of the organism can be augmented. We set out to identify similar
mutations by rotarod screening of 33,806 laboratory mice harboring chemically induced random mutations with
the goal of mechanistically explaining and, eventually, pharmacologically enabling the phenomenon of motor
superperformance. In this context, we have discovered that a mutation in an unsuspected gene, Rif1
(Replication Timing Regulatory Factor 1), confers supernormal motor ability. Using clustered regularly
interspaced short palindromic repeats (CRISPR) Rif1-mutant mice, we have determined that: 1) mutant
superperformance is a selective phenotype, with distinct changes in motor features quantifiable by our novel
analysis method, but no other effects upon rigorous behavioral testing, and 2) the mutation also leads to
accelerated motor recovery from stroke. The superperformance mechanism, however, is unknown: although
Rif1 participates in DNA repair and in transcriptional regulation via G4 folded DNA structural stabilization, little
is known about its function in the nervous system. There is precedent that DNA repair may be associated to
synaptic transmission strength, while DNA G4 regulation could enhance the transcription of genes active in the
motor system. We have refined this hypothetical framework by identifying several consequences of the Rif1
mutation: a) Increased cerebellar Purkinje cell firing regularity and local field potential changes in the non-
moving mouse, which can influence movement precision, with change of these neurophysiological parameters
upon locomotion on a treadmill; b) Increased resistance to DNA-damaging radiation; c) Increased resistance to
G4 stabilization; d) Overexpression of a fraction of the cerebellar (but not forebrain or spinal cord) synaptic
transcriptome including potential Rif1 mutation mediators such as Kcnma1, Kif5c and Nab2; e) These
transcripts may be relevant to the phenotype because we show that loss of function mutations in them degrade
motor performance, whereas f) Cerebellar injection of adenovirus-containing Nab2 induces superperformance.
This proposal unifies this body of work by postulating that the Rif1 mutation modifies DNA repair and/or G4
DNA folding resulting in upregulation of synaptic transcripts, with either one or both mechanisms augmenting
the precision of cerebellar synapse activity relevant to movement control. To this effect, we will conduct
neurophysiological studies, determine the transcriptome in single cells, alter Kcnma1, Kif5c and Nab2
expression, and investigate DNA repair and DNA G4 regulation to test which of these mechanisms enable the
superperformance phenotype. Our goal is to initiate and steer the mechanistic investigation (by us or any
others) of Rif1 in the brain for ultimate therapeutic gain if appropriate.

Public health relevance
PROJECT NARRATIVE Most drugs influence the activity of specific molecules, limiting or repressing one or more functions in the cells on which they act. In contrast, the study of genes and gene products that allow, when altered, the emergence of supernormal (rather than limited) capacities fulfills the mission of the National Institutes of Health by enabling the future development of drugs that can reproduce this augmentative influence or action. Understanding and modifying how such genes work harbors the potential to enhance human performance (in this case, motor performance) to counteract a variety of neurological disorders that impair human mobility.